A TOPICAL ETHOXZOLAMIDE ANALOG FOR USE IN GLAUCOMA

Specific analogs of ethoxzolamide will be synthesized and evaluated. These analogs are designed for the purpose of promoting penetration and distribution into the eye from a topically applied dose. From previous results and based upon a mathematical model, four additional 6-substituted analogs of ethoxzolamide will be synthesized: methylamino, acetamino, methoxymethyl and carboxyethyl. These are classical inhibitors designed for optimal corneal transport. In addition to optimal transport, a 6-amino analog of ethoxzolamide has been found to be five-fold more potent than ethxzolamide. Lipophilic substitution will optimize its transport. Furthermore, N-alkyl and/or N-hydroxyl sulfonamides have been identified which are potent "nonclassical" inhibitors of carbonic anhydrase. Their potency will be optimized by systematically synthesizing various N-substituted sulfonamides. These results will provide information for the design, synthesis and evaluation of 6-substituted and N-substituted ethoxzolamide analogs. These analogs will represent both optimal corneal transport and optimal potency. The following information will be determined for most synthesized analogs; physical-chemical properties (partition coefficients, CAI, pKa and excised corneal permeability coefficients), pharmacological properties (duration of intraocular pressure, dose-response, and efficacy of repeated doses), pharmacokinetic properties (iris/ciliary body, aqueous humor, cornea and blood concentrations over time) and biochemical properties (type of carbonic anhydrase inhibition and Ki values). From this work a topical carbonic anhydrase inhibitor will be identified as a candidate for testing in glaucoma patients.